Unpredictable Parent Behavior in Infancy and Subsequent Emotion Regulation, Brain Function, and Psychopathology

PROJECT SUMMARY
Early caregiving is a critical determinant of healthy socio-emotional development and the capacity for adaptive
emotion regulation (ER). Parental socio-emotional signals (e.g., warmth, support, responsiveness) during
infancy are critical for the development of ER and protection against emotion dysregulation, a transdiagnostic
indicator of risk for child psychopathology. Yet, the mechanisms by which parent behavior influences brain
systems that support ER to increase psychiatric risk are unknown. Animal studies identify unpredictability (UN),
the entropy in the patterns in parent behavior, as one mechanism by which parenting directly alters the
maturation of emotional circuits. In parallel human studies, high UN in parent sensory signals (UN-sens;
transitions between visual, auditory, and tactile behaviors) during infancy predicts childhood deficits in effortful
control. This K01 will expand upon these findings and test the hypothesis that the UN of parent socio-emotional
signals (UN-emo; the inconsistency of nurturing/supportive behaviors) observed during the first year of life alters
the neurodevelopment of ER to increase risk for child psychopathology. Specifically, this K01 will investigate
how UN-emo observed in early parent behavior relates to subsequent brain function (functional connectivity and
evoked responses) supporting ER in early childhood. This K01 offers an unprecedented opportunity to address
critical gaps in the mechanisms underlying the relationship between early caregiving, development of ER, and
risk for psychopathology by testing an integrative model that incorporates biological, behavioral, and experiential
factors. This time-sensitive innovative proposal leverages a rich, ongoing longitudinal study from birth to age 8
years with existing or ongoing observational (parent-child interactions), behavioral (ER), brain imaging (resting-
state fMRI), and clinical (psychopathology) data. The applicant will add new coding (UN) and data collection
(movie-fMRI) to investigate the impact of UN in parent behavior (both UN-sens and UN-emo) at age 1 year on
the development of ER (age 1-6 years) and the functioning of brain systems supporting ER (age 6 years)
including their role in predicting child psychopathology. Dissecting how early ER and brain function that support
ER are altered by early caregiving will motivate and inform the design of novel parenting interventions that
decrease UN-emo and resulting psychiatric risk. When combined with her extensive neuroimaging experience,
background in functional brain organization, and expertise in complex computational techniques, the proposed
targeted training in 1) observation of parenting during infancy, 2) measurement of early indicators of child
psychopathology, and 3) examination of brain function in early childhood using movie-fMRI will uniquely enable
the applicant to apply a developmental neuroscience approach to investigate how the emerging parent-child
relationship shapes developing brain function to predispose children to psychopathology. This K01 will facilitate
an R01 proposal that uncovers the mechanisms by which early parent behavior impacts the development,
organization, and functioning of brain systems that underlie mental health problems, beginning in infancy.

Public health relevance
PROJECT NARRATIVE Early caregiving is a critical determinant of the ability to monitor and control emotional responses to internal and external experiences, yet the mechanisms by which parent socio-emotional signals, such as warmth and sensitivity, influence brain systems that support healthy development of emotion regulation remain unknown. Translating recent findings from cross-species models of parenting and neural development, this prospective longitudinal study tests the hypothesis that the unpredictability of parent socio-emotional signals during infancy alters the early development and functioning of brain systems that support emotion regulation to increase risk for child psychopathology. Findings from this study will elucidate unpredictability as a modifiable component of parent behavior that can be targeted in early parent-child interventions to support emerging emotion regulation and brain function to reduce psychiatric risk.